Mitochondria-mediated effects and therapeutic potential of Atrial Natriuretic Peptide in salt-sensitive hypertension

PROJECT SUMMARY
There is no specific treatment available for the subpopulation of patients with salt sensitivity of blood pressure
(BP); unfortunately, the molecular mechanisms underlying salt-sensitivity remain poorly understood. One of the
major proposed mechanisms for the development of salt-sensitive (SS) hypertension involves a defect in the
ability of the kidneys to excrete salt. Atrial Natriuretic Peptide (ANP) encoded by Nppa, is a hormone known to
promote salt excretion and BP reduction, and there are clinical data implicating inherently low levels of ANP in
the development of SS hypertension. Among other effects, ANP (via cGMP-related mechanisms) is known to be
beneficial for mitochondrial bioenergetics and biogenesis. However, there is a gap in knowledge regarding the
effects of ANP on mitochondria in the kidney, especially in SS hypertension. Our pilot studies demonstrated
that during a high salt challenge Nppa-/- (ANP knockout) Dahl SS rats exhibit exacerbated salt-sensitivity,
reduced sodium excretion, and aggravated kidney injury, which is associated with mitochondrial damage and
dysfunction. We also showed that there is dysregulation of renal sodium transporters, in the Nppa-/- rats
compared to wild-type controls, and the activity of the Epithelial Na+ Channel (ENaC) is elevated in the collecting
ducts. Chronic ANP infusion in wild-type SS rats resulted in a dramatic attenuation of salt-induced BP increase
and alleviated organ damage.
We hypothesize that in SS hypertension ANP deficiency/reduced sensitivity to ANP is causative to renal
mitochondrial dysfunction and associated sodium transport imbalance. To address the central hypothesis of this
project, we developed three specific aims: Aim 1. Establish whether increased ANP levels are beneficial for
renal salt handling and cardiac function in SS hypertension. Aim 2. Determine whether low renal cGMP level
resulting from lack of ANP causes an increase in renal mitochondrial Ca2+ and reactive oxygen species (ROS).
Aim 3. Test the hypothesis that disrupted Ca2+ balance and excessive ROS production by dysfunctional
mitochondria affect renal sodium handling in SS hypertension.
We generated abundant evidence to support these aims, created a rigorous and comprehensive experimental
design and established novel cutting-edge techniques to address the hypothesis. We recruited strong
collaborative expertise, and will implement a combination of whole-animal studies and in vivo techniques (blood
pressure monitoring with drug infusion, metabolic studies and GFR measurements), electrophysiology (single
channel and whole-cell patch-clamp of the freshly isolated nephrons and isolated mitochondria), advanced
microscopy, mitochondrial spectrofluorimetry and respirometry, and routine molecular biology approaches. The
successful completion of the proposed studies will unravel the novel causative mechanisms of salt-sensitivity.

Public health relevance
PROJECT NARRATIVE In salt sensitive (SS) hypertension, an increase in dietary salt intake causes an elevation in blood pressure, which largely happens due to a pathological inability of the kidneys to get rid of the salt. Existing hypertension treatment strategies are often ineffective for salt-sensitive people. This proposal is focused on the renal mechanisms of salt-sensitive hypertension development. Specifically, we will look into mitochondria function and energy metabolism regulated by a crucial hormone (atrial natriuretic peptide), that is known to be decreased in SS individuals. We will seek novel mitochondria-related targets for the treatment of this disease.